Development of Broadly Protective Vaccines against New World Arenaviruses

Abstract
Mammarenaviruses, or arenaviruses, can cause a range of diseases in humans, including congenital disorders,
encephalitis, meningitis, and severe hemorrhagic fevers (HFs). Arenaviruses are divided into Old World (OW)
and New World (NW) groups. Several NW arenaviruses, such as Junín (JUNV), Machupo (MACV), Guanarito
(GTOV), Chapare (CHAPV), and Sabiá (SABV), are endemic in South America and can cause HF infections in
humans with fatality rates reaching up to 30%. Other uncharacterized or unknown NW arenaviruses may include
potential pathogens. To date, there are no FDA-approved vaccines or therapeutics for arenaviruses. Candid#1,
a live attenuated JUNV vaccine, is licensed for use in Argentina against JUNV-caused Argentine HF, but is
unlikely to be approved by the FDA due to safety concerns. There is an urgent need for vaccines to prevent
current and future arenavirus outbreaks. Our long-term goal is to create safe and effective vaccines against
pathogenic arenaviruses. The objective of this R01 proposal is to leverage the unique properties of a viral
vaccine vector rP18tri based on a non-pathogenic NW arenavirus, Pichinde virus (PICV), to develop safe and
broadly protective vaccines against NW arenaviral pathogens. PICV has no to low seroprevalence in humans,
even in endemic areas in Colombia, South America. The rP18tri-based live-attenuated vaccines show limited
replication in the vaccinated animals, with no evidence of viremia or virus shedding. They induce a balanced
level of antigen-specific antibody and T-cell responses, which can be further enhanced by homologous boosting.
Our compelling preliminary data demonstrate that the rP18tri-based JUNV vaccines are safe and can provide
complete protection against virulent JUNV challenges in guinea pigs. Furthermore, the rP18tri vector alone can
confer partial protection against JUNV, underscoring its potential to elicit broadly protective immunity against
diverse NW arenaviruses. We hypothesize that the non-pathogenic arenavirus vector (rP18tri)-based vaccines
expressing multivalent antigens from JUNV and MACV will elicit robust and broadly protective immunity against
various NW arenaviruses. We have assembled a multi-institutional team of investigators with complementing
expertise in molecular virology, viral vector and vaccine development, guinea pig T cell immunology, and animal
modeling of arenavirus HFs in the BSL3/4 facilities. We will produce a panel of rP18tri-based NW arenavirus
vaccines expressing one or two antigens (glycoprotein GPC and nucleoprotein NP) from JUNV and MACV,
evaluate their immunogenicity and protective efficacy against homologous (Aim 1) and heterologous (Aim 2)
virus challenge in established guinea pig models, and characterize vaccine-induced protective immunity (Aim
3). Impact: The study will generate safe and broadly protective NW arenaviral vaccine candidates for subsequent
preclinical and clinical evaluation, generate new knowledge about the protective antigen(s) and immunity to guide
the design of next-generation arenavirus vaccines, and advance the rP18tri platform for developing vaccines
and immune therapies against communicable and noncommunicable diseases, such as cancers, in humans.

Public health relevance
Project Narrative: Multiple New World (NW) arenaviruses can cause lethal hemorrhagic fever disease in humans and no FDA- approved vaccines or effective therapeutics have been developed targeting these pathogens. We propose to use a non-pathogenic arenavirus (Pichinde virus)-based vector platform to develop safe and broadly effective NW arenavirus vaccines. These vaccines will protect against emerging and re-emerging NW arenavirus pathogens.